Peripheral Nerve-on-a-chip for Predictive Preclinical Pharmaceutical Testing

PROJECT SUMMARY
The drug development pipeline is plagued by unacceptable rates of attrition due in large part to toxicities that
are not identified in pre-clinical stages of development. While peripheral neuropathy remains a common toxic
side-effect of new drugs, such toxicity is typically only first identified during late-stage preclinical development or
even early clinical trials. Drug-induced neurotoxicity is caused by off-target effects of pharmaceuticals that lead
to sensory, motor, and cognitive deficits. While rarely fatal, drug-induced peripheral neurotoxicity can lead to
permanent nerve damage and in some cases can be a dose-limiting side effect, leading patients to reduce
dosage or stop treatment altogether. “Organ-on-a-chip” technologies are steadily becoming adopted by the
pharmaceutical industry because of their ability to help de-risk lead compounds during pre-clinical development.
Towards that end, we demonstrated the technical feasibility and successful commercial deployment of a
peripheral “nerve-on-a-chip,” consisting of a 3D neuronal/glial spheroid projecting dense axonal fiber tracts,
resembling peripheral nerve anatomy. Progress during the prior award phases strongly demonstrated the
feasibility of using microengineered neural tissues that are amenable to morphological and physiological
measurements analogous to those of clinical tests. The use of structural and functional analyses in vitro led to
drug-induced neural toxicity that manifested in ways analogous to clinical neuropathology. Valuable feedback
from industry early adopters has enabled us to revise previous assumptions and resolve many technical
challenges, and we now seek to deploy the technology at a commercial scale. The aims of this proposal are to
manufacture customer-ready multiwell devices with integrated microelectrodes, and to provide a more complete
biological characterization of our model using high-throughput transcriptomics. Completion of these aims will
position this technology for scalable implementation, enabling us to offer the platform widely to pharmaceutical
companies seeking information about peripheral neuropathy earlier in the preclinical drug development process
than currently possible.

Public health relevance
PROJECT NARRATIVE Current methods available for bringing drugs to market have resulted in high attrition rates as compounds progress through the drug pipeline, resulting in unacceptable clinical trial toxicity and skyrocketing pharmaceutical prices. Improving the predictive power of preclinical models represents the fastest and most competitive method to advance the safety and time to market for new therapeutics. As an added benefit, decreased drug development costs should also expand the availability of novel treatment options for patients.